The role of primary cilia and C2cd3 in craniofacial skeletogenesis

ABSTRACT:
Primary cilia are ubiquitous, microtubule-based extensions that transduce molecular signals within
a cell. Defects in primary cilia result in ciliopathies, a pleiotropic group of debilitating, and
sometimes life-threatening disorders. One third of ciliopathies are defined by severe craniofacial
anomalies. Currently there are no recognized treatments for these patients, mostly because we have
an incomplete understanding of how the cilium integrates cellular/molecular signals and influences
cell behaviors. Oral-facial-digital syndrome 14 (OFD14) is a human ciliopathy that is caused by
mutations in the centriolar protein, C2 Calcium-Dependent Domain Containing 3 (C2CD3) and is
characterized by multiple craniofacial skeletal anomalies including cleft palate and micrognathia.
Our previous work revealed hypoplastic cranial neural crest cell (NCC) derived skeletal elements
in OFD14 models; however, the mechanism of how C2cd3 functions in this context is unknown.
Based on the known role of C2cd3 in ciliogenesis, its localization to the centriole, and the presence
of numerous C2 protein binding domains we hypothesize that the craniofacial phenotypes present
in OFD14 are molecularly due to impaired to Hh/Gli-driven NCC skeletal differentiation and
cellularly due to impaired association between the centriole and actin cytoskeleton. To test these
hypotheses, we will utilize knockdown and conditional knockout transgenic murine lines
(C2cd3Ex2; C2cd3Exon4-5fl/fl; C2cd3Exon9fl/fl) as well as human induced pluripotent stem cells
(hIPSCs) that either lack C2CD3 (C2CD3-/-) or carry OFD14 causing C2CD3 variants
(C2CD3Trp65Cys, C2CD3Ile477*). Experiments in this proposal will (Aim 1) determine if skeletal
differentiation is impaired in hIPSC-derived NCCs carrying OFD14 causing C2CD3 variants,
(Aim 2) determine if C2CD3 functions to anchor the centriole to the actin cytoskeleton and if
OFD14 causing C2CD3 variants impair this association, and (Aim 3) test if C2cd3 mutations and
OFD14 causing C2CD3 variants impair Gli3/DNA and Gli3/co-factor binding, and subsequent
Gli3 transcription. Together these studies will address both the cellular and molecular etiology of
the human ciliopathy OFD14 and identify possible areas of therapeutic intervention for
craniofacial phenotypes that arise in all ciliopathies.

Public health relevance
Narrative: Ciliopathies are a wide-ranging class of pleiotropic disorders caused by defects in a cellular organelle called the primary cilium. This project examines the cellular and molecular basis for skeletal phenotypes associated with the ciliopathy Oral-facial-digital syndrome-Type 14 (OFD14). Data from this project could identify possible avenues for therapeutic intervention for ciliopathies.